Virtual Reality Cognitive Therapy forAlzheimer's Disease

ABSTRACT
Alzheimer's disease (AD) and Alzheimer's disease-related Dementias (ADRD) currently affect more than 5.8
million Americans, costing $305 billion for treatment and management in 2020 and causing poor outcomes such
as loss of independence, low quality of life, and nursing home requirements. Given the scale of diminished
health-related quality of life, the need for non-invasive customizable cognitive impairment (CI) targeting methods
to assist AD patients is imperative. There is a significant need for effective individualized digital interventions for
AD patients accessible with social distancing in the COVID-19 pandemic situation.
Claritytek proposes to develop an evidence-based, non-invasive, novel tool targeting individual aging cognitive
deficits to improve AD/ADRD patients' quality of life. Virtual Reality Cognitive Therapy (VRCT) utilizes a four-
pronged approach: Assess, Educate, Treat, and Track. VR is immersive, isolating the patient from surrounding
distractions -- crucial for any CI intervention. Cognitive Interventions for AD should consider all facets of cognitive
deficits, especially skills impacting activities of daily living (ADL) and IADL (instrumental ADL). VRCT aims to
treat IADL disabilities impacting AD patients. VRCT training activities are designed to imitate real-life situations,
tailored to engage, adapt, challenge, simulating lifelike CI-producing scenarios in contexts where they occur.
Utilizing VRCT, repeated exposures to CI scenarios through game loops to gradually train patients in useful
skills: medical appointments, taking medications, shopping, and remembering names, faces, and directions to
places – to preserve and improve functional independence. Our system will include an optional mode for
asynchronous online therapist consultations without face-to-face contact, valuable during COVID-19 isolations.
We will expand, adapt, and build on our team’s prior successful work for Alzheimer’s patients with CI, ranked
among the top 5 innovations in the world at an international digital health competition.
We will partner with specialists at the HealthPartners Neuroscience Center for Alzheimer’s Research to
lead the trial and help design, develop, and optimize VRCT. We will incorporate stakeholder feedback to create
a patient-centric intervention targeting four specific prioritized "CI" related to IADL, utilizing guidelines of the
digital therapy development frameworks. To guide the project, we will create a multidisciplinary Expert Focus
Group (EFG).
In Aim 1, we will evaluate the feasibility, usability, and acceptability of VRCT on 36 AD/ADRD patients with mild
to moderate CI over seven weeks. We will conduct three trials, each trial with a cohort of n=12, total of n=36
participants. In addition to the patient’s responses to the therapy, a focus of the evaluation will be cognitive
tolerability, as the target patients have CI. The results from each trial will be applied iteratively in Aim 2 to revise
the VRCT before the next trial, producing the most acceptable CI intervention.
In Aim 2, we will iteratively redesign, develop, unit test, and optimize VRCT based on patients’ feedback from
the trials and EFG analysis. We expect to establish that VRCT will be feasible, usable, and acceptable with a
Usability Scale success rate of 90%, and user satisfaction of 80%.

Public health relevance
Narrative Cognitive Impairment (CI) is a serious problem associated with reduced quality of life and it places a significant burden on individuals, families, and society. In this project, we will develop a Virtual Reality Cognitive Therapy tool for Alzheimer’s disease patients with CI to remediate instrumental activities of daily living specific disabilities impacting patients everyday functioning, thus empowering the AD patients' to improve their quality of life. This tool would have significant public health relevance because the required equipment cost is modest and its use is self-managed, making it affordable for remote and low-resource settings such as underserved populations inside or outside the United states.